Impact of Heme Homeostasis on Adipocyte Function

ABSTRACT
Defects in adipocyte function drive the onset of systemic insulin resistance and obesity-linked diabetes.
Mitochondrial dysfunction is often associated with these obesity-induced abnormalities in adipocyte function.
Agents that can revert these defects are clinically useful insulin sensitizers in humans. Using innovative tools,
we recently isolated a small molecule that increased multiple aspects of adipocyte physiology and identified its
target as Progesterone Receptor Membrane Component 2 (PGRMC2), a protein with no prior link to adipocyte
function. The compound is not an inhibitor of PGRMC2, but rather, a gain-of-function ligand or activator.
Treatment of obese-diabetic mice with a derivative of this molecule increased insulin sensitivity and glucose
tolerance, indicating that activation of PGRMC2 function may be therapeutic. In contrast, adipose-specific
PGRMC2-null mice exhibit profound defects in mitochondrial function, adaptive thermogenesis, and systemic
glucose metabolism, highlighting the importance of PGRMC2 activity in adipocytes and systemic homeostasis.
PGRMC2 is a poorly-characterized single-pass transmembrane protein with a putative heme-binding domain. It
is localized in the endoplasmic reticulum and enriched in the nuclear envelope, and it reversibly binds heme.
To stimulate adipocyte differentiation, chemical activation of PGRMC2 requires Rev-Erba, an adipogenic
nuclear receptor whose natural ligand is heme, which suggests a role for PGRMC2 in heme trafficking. Heme
is an essential prosthetic group for many proteins, and a signaling molecule in diverse biological processes.
Because free heme is highly cytotoxic, heme-dependent processes require the rapid mobilization of heme to
hemoproteins present in every organelle. Heme synthesis and degradation pathways are well known, but how
heme synthesized in mitochondria reaches other organelles is not known. PGRMC2-null cells and tissues
show alterations in intracellular heme partitioning, with decreased signaling heme in the nucleus. Thus,
studying the function of PGRMC2 may provide the means to understand how heme is mobilized inside cells.
Our hypothesis is that PGRMC2 plays a key role in intracellular heme homeostasis, facilitating heme delivery
to the nucleus, and that this process is critical for adipocyte function and systemic physiology.
This work may validate PGRMC2 as the first intracellular heme chaperone identified in mammals, one involved
in transport of heme from mitochondria to the nucleus. It will also reveal the impact of heme metabolism on
adipocyte function and systemic physiology. Further, because pharmacological activation of PGRMC2 has
anti-diabetic effects, greater understanding of the function of PGRMC2 may provide the rationale to develop
small-molecule PGRMC2 activators as insulin sensitizers.

Public health relevance
PROJECT NARRATIVE This project will study the role of a poorly-characterized protein in fat cells and trafficking of heme, a molecule essential for life, and its impact on organismal physiology. Because obesity-linked adipocyte defects drive systemic insulin resistance and type 2 diabetes, and this protein can be targeted with drugs, this work may furnish a new drug target to treat diabetes and associated conditions.